Ixodes scapularis Immuno-Developmental and Metabolic Signaling Pathways and Interference with Ticks and Tick-borne Pathogens

OVERALL – Abstract
The proposed renewal Program Project (P01), entitled “Ixodes scapularis Immuno-Developmental and
Metabolic Signaling Pathways and Interference with Ticks and Tick-borne Pathogens”, aims to
understand the molecular mechanisms by which a set of newly recognized I. scapularis conserved signaling
pathways, either discretely or via synergism, govern key episodes of arthropod development, metabolism, and
immunobiology that shape their vectorial competence for the harboring and transmission of agents of Lyme
disease and anaplasmosis. We have discovered unorthodox aspects of tick signaling pathways that involve
mammalian-arthropodal crosstalk and are triggered by ingested cytokines, scavenger receptor-like proteins, or
hormones, and influence tick microbicidal responses, development, and/or metabolism, as exemplified by the
Dome1-JAK-STAT, immune deficiency (IMD), and adiponectin receptor-like protein (ISARL) signaling
pathways. We have also established that suppressing the expression of select key extracellular components
of these signaling pathways, such as via RNA interference-mediated knockdown of cell surface tick receptors
or extracellular molecules, interrupts tick engorgement or pathogen transmission. In this renewal application,
which builds on these paradigms and combines the complementary expertise and resources from four
institutions with impressive histories of research involving tick-borne infections, we propose to further
characterize these signaling pathways and explore whether essential cell surface tick receptors, domains,
and/or extracellular molecules could be targeted as novel anti-tick vaccines to impede essential aspects of
vector biology and tick-pathogen life cycles. Two of the most widespread and emerging bacterial pathogens,
Borrelia burgdorferi and Anaplasma phagocytophilum, remain our focus as prototypic examples of tick-
transmitted extracellular and intracellular microbes, respectively. This renewal Program Project Grant
leverages specific assays, tools, and methodologies developed by our laboratories, supported by an
Administrative Core and Tick Resources Core, whereby new information as well as organisms, cell lines, and
resources will be generated and shared, not only among the P01 team, but also with broader scientific
communities via open-source databases, platforms, and the project website. The proposed goals are to: 1)
Operate Resource Cores that provide research reagents and information to all Projects and the scientific
community; 2) Characterize signaling pathways regulating vector immune-developmental cascades; 3)
Investigate metabolic pathways regulating tick immune responses; and 4) Explore tick immune-developmental
and metabolic pathways as anti-tick vaccine targets. Altogether, this proposal will increase our understanding
of atypical tick biology and advance the development of new preventions against major tick-borne infections,
while also planting new seeds of innovative research in vector-borne infections and enticing a new generation
of scientists to engage in and advance this important yet neglected field of scientific research.

Public health relevance
OVERALL – Narrative Two of the most prevalent vector-borne human diseases in the United States and many parts of Europe are Lyme disease and anaplasmosis, caused by the bacterial pathogens Borrelia burgdorferi and Anaplasma phagocytophilum, respectively, which are transmitted by the black-legged tick, Ixodes scapularis. A collaborative research effort in this renewal Program Project Grant seeks to provide details on the molecular and mechanistic aspects of several tick signaling pathways that govern key episodes of tick biology and vectorial competence. We will explore whether the targeting of select components of these signaling pathways, in the form of novel anti-tick vaccines, prevents tick engorgement on hosts and blocks the transmission of multiple tick-borne infections like Lyme disease and anaplasmosis.